Sequencing by Direct Electrical Measurements of Polymerase Fluctuations

PROJECT SUMMARY
Our goal is to create a low-cost, high speed single-molecule genome sequencer with long reads, requiring no
dyes or labels, with direct electronic readout. The technology has the potential for rapid reads (on the order of
an hour per genome) using an integrated circuit chip based on simple two terminal devices. If this potential were
to be fully realized, then use of genome sequencing in the clinic with near real-time feedback could become a
reality. Our data shows that large-amplitude polymerase fluctuations are associated with polymerase activity.
Our first goal is to identify signals associated with each nucleotide incorporation with high accuracy. This would
enable sequencing by means of cyclic addition of nucleotides, but with the advantage that homopolymer runs of
sequence would be counted directly. Our second aim is to identify the individual nucleotides being incorporated
based on the details of the signals generated at each incorporation. This would allow a sequencer to run at the
free-running speed of the polymerase in the presence of all four nucleotidetriphosphates, so that a wafer of
10,000 devices could produce a genome's worth of reads in an hour. Our third aim is to develop scalable
technology for fabrication of prototype solid-state devices.

Public health relevance
PROJECT NARRATIVE Direct measurements of DNA polymerase fluctuations has the potential for sequencing DNA with long and rapid reads (on the order of an hour per genome) using an integrated circuit chip. If this potential were to be fully realized, then use of genome sequencing in the clinic with near real-time feedback could become a reality.